Task B10: Evaluation of vaccines against VEEV and EEEV aerosol exposure in cynomolgus macaques

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.